The Role of Short-Chain Fatty Acid Sensing in Regulating Hepatic Glucose Production

The prevalence of diabetes continues to rise unabated in the United States, creating a grave
social and economic burden. Current pharmacological treatments are only moderately
effective at lowering glycemia, while metabolic surgery is effective, yet highly invasive.
Interestingly, both therapeutic options alter the gut microbiota, the collection of all the
microbes residing in the gastrointestinal tract, highlighting the role of gut microbes in the
development and amelioration of diabetes. The long-term goal of this project is to better
understand the mechanisms of the gut microbiota impacting glucose homeostasis.
Prebiotics represent one of the more promising dietary strategies to alter the gut
microbiota composition and improve metabolic dysregulation. Treatment with oligofructose
(OFS), a non-digestible fiber, lowers blood glucose levels, improves glucose tolerance, and
increases production of short-chain fatty acids (SCFAs) in the distal intestine. As such, SCFA
treatment also results in metabolic benefits, including weight loss and improved glucose
tolerance. Despite this, how SCFAs improves glucose homeostasis, and whether these
mechanisms are required for the beneficial effects of prebiotics, remains unknown. For
example, small intestinal propionate infusion activates a gut-brain-liver axis to lower hepatic
glucose production, but whether this pathway exists in the colon, where the majority of SCFAs
are produced, is unknown. Furthermore, SCFAs can enter the portal vein and act on the liver,
but their role in hepatic glucose regulation is not clear. Interestingly, butyrate and propionate
can act as epigenetic regulators, inhibiting histone deacetylases (HDACs), but it is unknown
whether SCFAs affect downstream hepatic transcription factors that directly regulate hepatic
gluconeogenesis. This, with our preliminary data, led to the hypothesis that SCFAs improve
glucose tolerance by directly and indirectly targeting hepatic glucose production (HGP), both
pathways of which are responsible for mediating the beneficial effects of OFS treatment. By
utilizing sophisticated in-vivo surgical and viral manipulations during glucose tolerance tests or
pancreatic clamps, this hypothesis will be tested in 3 aims: 1) determine if preabsorptive SCFAs
activates a colonic-brain-liver axis to lower HGP, 2) examine the ability of portal SCFAs to inhibit
HDAC activity to lower HGP, and 3) determine if gut-brain-liver axis signaling or hepatic HDAC
inhibition are responsible for the glucoregulatory benefits of prebiotics due to increased SCFAs.
A better understanding of how prebiotics and SCFAs improve glucose homeostasis could lead
to targeted therapies that reduce chronically elevated HGP during diabetes.

Public health relevance
Diabetes has reached epidemic levels in the United States, underscoring the critical need for safe, effective treatment options. Prebiotics, non-viable food components that modulate the microbiota, can improve glucose homeostasis, but the mechanism of action is unclear. The current work will unravel the mechanisms upon which prebiotics improve glucose homeostasis via increases in short chain fatty acid production, hopefully leading to more targeted therapeutic approaches to treat diabetes.